Mindfulness-Based Cognitive Therapy for the chronic pain-depression co-morbidity among older Blacks in the community; The Quiet Focus study

This K23 proposal details a comprehensive 5-year training program that will support the candidate’s transition towards becoming an independent investigator. The candidate (Dr. Tony V Pham) will focus his career on developing and rigorously testing mind-body interventions with better access and relevance to communities experiencing health disparities. In this application, the candidate proposes to address the chronic pain-depression co-morbidity in the older Black community by adapting mindfulness-based cognitive therapy (MBCT). Among older Black adults, chronic pain more often co-occurs with depression, and this co-morbidity worsens physical and emotional function. An adapted MBCT may be an effective and efficient solution to improve physical and emotional outcomes among this population. This K23 will develop Quiet Focus, an adaptation of MBCT for older Black adults with chronic musculoskeletal pain and co-occurring depression. My preliminary conversations with the community revealed strong interest in Quiet Focus, support for MBCT’s relevance to the community, and interest in participation only if the intervention is abbreviated and is delivered by a peer lay instructor. In Aim 1, I will develop Quiet Focus using guidance from the older Black community with chronic pain and co-occurring depression. The starting point for Quiet Focus will be an abbreviated, evidence-based MBCT protocol (8 60-minute sessions) developed by co-mentor Shallcross. I will train lay instructors under the mentorship of co-mentor Joo and develop a fidelity protocol under the mentorship of primary mentor Vranceanu and co-mentor Shallcross. In Aim 2, I will train a lay individual to deliver Quiet Focus and assess preliminary feasibility and fidelity. In Aim 3, I will train a new lay individual to deliver Quiet Focus and another to deliver a time- and dose-matched control. I will then conduct a feasibility RCT of Quiet Focus and control and assess definitive feasibility benchmarks including fidelity. These proposed efforts will inform an efficacy trial through the R01 mechanism (primary outcome is physical function) as well as future studies aimed at generalizing this work to other communities experiencing health disparities. These study aims are supported by 3 main training goals aimed at developing expertise in: (1) community engaged intervention development, (2) mixed methods research for intervention refinement, and (3) community-engaged clinical trials. These training goals are supported by (1) a team of expert mentors (Vranceanu, Joo, and Shallcross), advisors (Mischoulon, Parker, Okereke), and a community advisory board (Jacqueline Hinton, Central Boston Elder Services; Michael Kincade, Massachusetts General Hospital), (2) a rich institutional environment, and (3) targeted coursework, workshops, scientific meetings, seminars, and planned publications. For the past year, I have built the infrastructure for this proposal through formal and informal meetings with community leaders and groups of older Black adults with chronic pain and co-occurring depression. This K23 proposal is in line with NCCIH’s funding priorities to advance how complementary and integrative health practices can improve pain outcomes and address the whole person.

Public health relevance
Co-morbid chronic pain-depression is more common among older Black adults and this co-morbidity worsens physical and emotional function. Mindfulness based cognitive therapy (MBCT) is an evidence-based, non-pharmacological intervention that could address the chronic pain-depression co-morbidity among older Black adults, but it requires tailoring. The proposed study will establish the feasibility, acceptability and credibility of Quiet Focus, an adaptation of MBCT aimed at the chronic pain-depression co-morbidity among older Black adults in the community.